Intracellular Osteopontin induces Pathologic Macrophage phenotypes in Pulmonary Fibrosis

PROJECT SUMMARY
Although treatments have been approved, the etiology idiopathic pulmonary fibrosis (IPF), a progressive
interstitial lung disease with extremely poor outcomes, remains elusive and patient wellbeing continues to decline
on therapy. Further, non-specific steroid treatment has increased IPF mortality, highlighting the need for deeper
mechanistic understanding of IPF initiation and progression. Many human and in vivo modeling studies have
identified a central role for alveolar macrophages in the promotion of pulmonary fibrosis through the cytokine-
mediated activation and polarization of fibroblasts. Further, osteopontin (OPN, Spp1 gene) upregulation is a
hallmark finding in IPF biopsies and mouse models and commonly defines pro-fibrotic alveolar macrophages.
Crucially, our lab has identified that OPN has two functionally distinct isoforms generated by alternative
translation. Pulmonary fibrosis studies of OPN thus far almost exclusively analyze the summative actions of the
secreted (sOPN) and intracellular (iOPN) isoforms. While some possible sOPN functions have been described
in vitro, the role of iOPN remains entirely unexplored in pulmonary fibrosis. Our recent preliminary data has
identified that iOPN activates mTOR, promotes a fibrotic macrophage phenotype, and is sufficient to induce
disease in vivo.
Further, my data suggest that OPN is essential for the development of Trained Immunity. As an innate
immune memory program, Trained Immunity confers enhanced secondary responses from inflammation-
experienced myeloid cells. Given that IPF is thought to involve repeated epithelial injury, resident immune cells
are likely trained to form memory of the sequential inflammation. These immunological adaptations of resident
cells may represent a mechanism of disease progression due to each exacerbation producing cycles of epithelial
injury, alveolar macrophage training, and enhanced collagen deposition by activated fibroblasts. These data
indicate that the previously unrecognized iOPN isoform may represent a central regulator of fibrosis induction
and disease progression, explaining, in part, its consistent association with IPF severity.
In this proposal, I will uncover the mechanism of iOPN-dependent mTOR activation and Trained Immunity
and determine their contribution to lung fibrosis pathology in vivo. By studying the isoform-specific roles of OPN
in pulmonary fibrosis, this research will bring crucial mechanistic context to our understanding of IPF
pathophysiology and has the potential to illuminate new therapeutic targets.

Public health relevance
PROJECT NARRATIVE The association of idiopathic pulmonary fibrosis (IPF) with the scaffold protein osteopontin (OPN) is strong and consistent, but without considering the isoform variants of OPN, studies fail to fully elucidate their critical function in IPF promotion. This proposal will investigate the mechanism of intracellular OPN’s induction of fibrosis and its role in Trained Immunity, an innate memory program that may represent an immunological mechanism of IPF progression. This work will define a novel mechanistic understanding of OPN in IPF initiation and progression and has the potential to elucidate targeted therapeutic strategies.